Development of a Remotely Deliverable Cognitive Assessment Sensitive to Early Stage Mild Cognitive Impairment.

Abstract
With the aging of the population, the risk for age-related conditions such as Alzheimer’s disease(AD) and its
common precursor, MCI, is increasing. However, studies targeting prevention of MCI and AD have commonly
failed and part of the reason may be failures in selection of a population that is still at risk and has not yet
developed fully syndromal MCI. This project leverages our experience with novel semantic interference
paradigms and proposes to develop a widely accessible version of the Loewenstein-Acevedo Scales for
Semantic Interference and Learning (LASSI-L). As noted in the body of the application, the LASSI-L has shown
significant promise for the early detection of pre-MCI, in both national and international studies including
identification of individuals with evidence of amyloid deposition in the absence of detectable cognitive
impairments with standard neuropsychological measures. A computerized version of the LASSI, the LASSI-
Brief Computerized (LASSI-BC) version has been developed and validated on a preliminary basis in our NIH
funded studies but requires significant refinement to make it applicable for commercial use. The goal of this
phase II SBIR is to develop the next generation of semantic interference measures (LASSI-D), by making it
feasible to remotely deliver and score, for both large-scale clinical trials screening and clinical use. Given the
millions of individuals in the US and the rest of the world who are at risk for development of dementia, early
intervention is critical and the availability of such as assessment strategy would broadly increase access to
early screening and detection. The proposed Phase II SBIR is responsive to PAS-19-316, SBIR Phase II. In
specific, this application is directly focused on development of: “Sensitive, specific, and standardized tests for
diagnostic screening of mild cognitive impairment (MCI) and dementia, including the development of new, cost-
effective, minimally-invasive biomarkers that could be used for screening in the general population and in
community settings”. In this study we will evaluate whether the LASSI-D is also sensitive to the earliest phase
of MCI as well as being related to blood-based amyloid and tau biomarkers. This system will be designed to be
self- administered and hence to be widely useful for large- scale clinical trial screening in the general
population and clinical use in community settings.Our company is conducting a phase II SBIR focused on a
self-administered system for the treatment of functional deficits in MCI and the cloud-based platform for
delivery ofthe functional skills assessment and training program (FUNSAT) will be used for the development of
the LASSI-D. Our long-term goal is to develop a commercially successful suite of products that can help
identify risk for, prevent, and treat cognitive and functional declines and maintain the cognitive health and
functional independence of older adults. Commercialization efforts have begun for both FUNSAT and LASSI-L
and we have commitments from several large-scale potential customers.

Public health relevance
PROJECT NARRATIVE The population is aging and cognitive impairments, which adversely impact abilities important to everyday functioning and threaten independence, are common among older adults. This Phase II SBIR will develop and validate a web-based fully automated computerized assessment system focusing on detection of mild cognitive impairment at its earliest stages, which will be suitable to be self- administered under the supervision of a health care professional or clinical trials research staff for. This will allow for both broad accessibility of clinically focused assessment to older adult populations and provide rapid and valid screening for entry into prevention trials targeting Alzheimer’s Disease, which will likely be continuing to increase as efforts are undertaken to prevent Alzheimer’s Disease.